IGF::OT::IGF NHLBI Forum on Heart, Lung, and Sleep Disorders in American Indian/Alaska Native/Native Hawaiian (AI/AN/NH) Youth

Logistical support services for NHLBI Forum on Heart, Lung, and Sleep Disorders in American Indian/Alaska Native/Native Hawaiian (AI/AN/NH) Youth.